The BMRB as an evolving resource for biomolecular structure-function research

PROJECT SUMMARY/ABSTRACT
The BioMagResBank (BMRB) is the unique worldwide resource that provides free access to the wealth of
information on biomolecules derived from nuclear magnetic resonance (NMR) spectroscopy. These NMR
experimental data underlie the three-dimensional structures and conformations of many proteins and nucleic
acids and provide important insights into their dynamics, chemical properties, and molecular interactions. BMRB
maintains an open architecture and a defined and flexible data model that makes it possible to respond rapidly
to changes in standards for data exchange and to the steady advances in NMR technology (greater variety of
archived data and increasingly detailed associated metadata). Data archived at BMRB include primary data sets
(time-domain data) acquired under defined conditions and derived results, such as chemical shifts, peak
intensities, scalar couplings, dipolar couplings, relaxation rates, and cross relaxations. These parameters provide
information on molecular properties such as conformation, dynamics, ligand interactions, pKa values, and
hydrogen exchange rates. BMRB integrates these NMR data into a unified, global, macromolecular structure
database of general utility to the broad scientific community. The growing volume and diversity of data available
from BMRB are catalyzing transformative scientific applications, such as the determination of protein structure
and dynamics directly from chemical shifts. BMRB and its collaborators develop improved software tools for
integrating the retrieval, analysis, and display of NMR data in the context of molecular structure and
conformation. As a member of the World Wide Protein Data Bank (wwPDB), BMRB has close ties with the three
other wwPDB partners: the Research Collaboratory for Structural Bioinformatics (RCSB), the Protein Data Bank
in Europe (PDBe), and the Protein Data Bank of Japan (PDBj). In its role in the wwPDB BMRB sets standards
for NMR data types and develops software for data deposition and validation. The funds requested will enable
BMRB (1) to expand the diversity and level of coverage of biomolecular NMR data in response to community
needs, (2) to verify, reformat, archive, and distribute new data submitted electronically, (3) to maintain a
productive dialogue with users and creators of biomolecular NMR data, (4) to maintain and strengthen BMRB's
role in the wwPDB, (5) to collaborate with databanks specializing in related information so that useful links are
created, and (6) to interact with developers of new software and algorithms that make use of biomolecular NMR
data.

Public health relevance
PROJECT NARRATIVE The BioMagResBank (BMRB) data repository supports the biomedical research efforts of the world wide biological macromolecular magnetic resonance (MR) community. Magnetic resonance spectroscopy is a key tool used to understand the medical significance of protein and nucleic acid structure, to identify potential drug therapeutics, and to characterize metabolites and disease biomarkers.